Effects of Chromosomal Topology and Organization on E. coli Gene Expression

Project Summary/Abstract
Bacterial chromosomes are organized spatially and topologically within cells, taking on conformations
that change as a function of cellular processes, growth rates and conditions external to the cell. Nucleoid-
associated proteins facilitate this organization by bending, looping, and coating DNA to form topological
domains at different length levels. At the lowest level, the E. coli chromosome forms small looping domains, or
chromosomal topologically isolated domains (TIDs), on the order of 10 kbp. This chromosomal organization
into topologically isolated domains localizes supercoiling to different portions of the chromosome. The
relationship between this and transcription is one of coupling, where supercoiling density determines
transcriptional activity, but transcriptional activity also changes supercoiling density. To probe these effects and
to test our hypothesis that the formation of TIDs significantly modulates gene expression profiles we will use a
combined single-molecule imaging and computational modeling approach.
To learn the most about the DNA topological effects on transcription as we must be able to isolate the
various components in a series of synthetic systems. In Aim 1, I will construct an in vivo synthetic looping
domain to investigate the effect of domain formation on the transcription and expression dynamics of two
genes inside the domain under different conditions. Expression will be monitored via single molecule
fluorescence in situ hybridization and live protein expression from synthetic looping domains. In Aim 2, to
obtain a quantitative understanding of how the topological state of a TID impacts RNAP’s transcription kinetics,
I will monitor the initiation and elongation rates of single RNAP molecules on a circular template DNA
mimicking a TID using single molecule protein induced fluorescent enhancement (smPIFE) in vitro. In Aim 3,
to synthesize the models at these two size scales by using a reaction-diffusion model to simulate DNA-protein
interactions and supercoiling. Studying bacterial chromosomal organization in this way may reveal
mechanisms that bacteria use to maintain transcription in the presence of perturbations and ways they may
exploit DNA topology effects for gene regulation.

Public health relevance
Project Narrative A crucial step in gene expression is transcription, the first step of processing the information stored in DNA. Given that DNA is a polymer with mechanical topological and mechanical properties that affect how DNA- protein interactions, the spatial organization and torsional tension along the chromosome affect expression. Understanding how the conformation of the chromosome and the arrangement of genes along DNA lead to mutual interactions between genes that modulate gene expression is critical in being able to predict gene expression and phenotypic states.